GROWTH HORMONE LEVELS, PULSATIONS, IN GIRLS WITH IDIOPATHIC PRECOCIOUS PUBERTY

Girls with idiopathic precocious puberty have been receiving treatment with the luteinizing hormone releasing hormone a(LHRHa) for the past five years. Slow growth (less than 5cm/yr) has been observed in these girls during LHRHa therapy when their BA = 10-13 yrs. We propose to study 24 hr. growth hormone(GH) secretion in five girls before and during LHRHa therapy and in five girls without therapy to determine whether or not a change in GH secretion is responsible for the slow growth.